Doctoral Training in Brain and Behavioral Development During Adolescence (UCLA BBDA)

PROJECT SUMMARY
This application represents the first renewal request to continue support of the UCLA Predoctoral Training
Program in Brain and Behavioral Development during Adolescence (UCLA BBDA). UCLA BBDA leverages
UCLA’s internationally known strength in adolescence by integrating campus expertise in developmental
neuroscience and behavioral science to create a one-of-a-kind training experience that produces translational
scientists with the skills necessary to conduct research supporting the NICHD mission to “enhance the lives of
children and adolescents, and optimize abilities for all.”
The study of adolescent brain development has expanded dramatically over the past two decades, and
UCLA BBDA training focuses on four substantive growth areas necessary for the field to have translational
impact and improve the health and lives of the nation’s youth: (1) an integrative approach that incorporates
both typical and atypical brain development; (2) the interaction between brain development and the social
environment; (3) sophisticated approaches to examining longitudinal change over time; and (4) attention to
population diversity according to ethnicity and socioeconomic resources.
We accomplish this by providing an intensive mentored research experience, dedicated coursework
designed for the program, access to diverse faculty and research centers, as well as comprehensive
professional training that provides trainees with the toolkit necessary to become productive and impactful
independent scientists. As described in the Progress Report, we have had a successful first five years with 19
trainees working with 14 different primary and secondary mentors and who have demonstrated a strong level
of productivity. All of the 5 who have received their Ph.D. have obtained post-doctoral, research, and faculty
positions and the remainder are on track to complete their Ph.D’s in a timely fashion.
In the next five years, we aim to build upon our earlier successes and develop the program further by
adding new faculty and incorporating access to other resources on campus in order to provide additional
training opportunities in: (a) advanced methods in neuroimaging, such as structural and functional brain
connectivity; (b) biological markers of health; and (c) effective translation and dissemination of the science of
adolescence. Finally, we have continued and expanded upon our Recruitment Plan to Enhance Diversity in a
number of ways, such as partnering with UCLA initiatives focused on equity-minded recruitment and retention
and institutional efforts to recruit from national conferences drawing students from underrepresented
backgrounds. Collectively, these enhancements will help prepare our predoctoral trainees to position
themselves at the leading edge of the field and establish independent research careers that will further
NICHD’s mission of enabling children and adolescents to lead healthy and optimal lives.

Public health relevance
PROJECT NARRATIVE Capitalizing on UCLA’s unique strengths, we propose continuing a cutting-edge predoctoral training program in brain and behavioral development during adolescence to produce the next generation of scholars who can advance science and ultimately, enhance the health and well-being of adolescents.